Administrative

The functions of the Administrative Core are to provide day-to-day logistical coordination for the Program Project, and to facilitate scientific interactions between the various projects and cores. The goals of Core B are (1) to provide the platform for promoting maximum communication and exchange of ideas between Program Project members;(2) to monitor ongoing projects, assuring steady progress, and the timely reporting of results;and (3) to monitor the function and performance of the cores, and to provide ongoing assessment of whether they are serving the needs of the Program members in an optimal fashion. Specific activities will include (1) organization of monthly Program Project meetings and annual visits of the External Advisory Board;(2) preparation and submission of non-competing and competing renewal applications;and (3) the provision of secretarial support to the Principal Investigator on matters related to the Program Project.